Targeting bone marrow to treat renal disease

Project Summary/Abstract
The goal of this project is to explore a role for the bone marrow (BM) immune system in the pathogenesis of
idiopathic nephrotic syndrome (NS) and uncover key immune signatures of the disease. Inflammation and
immune system activation have long been considered the major culprits of idiopathic NS, yet the underlying
mechanisms are still poorly understood. Primary focal segmental glomerular sclerosis (FSGS) is one of the most
common causes of non-familial idiopathic NS in adults. While it is often responsive to immunosuppressive
therapy, in many cases patients experience a progressive loss of renal function. Moreover, about 30~50% of
FSGS cases recur in newly transplanted kidneys. While its incidence keeps rising, there is no cure for FSGS,
and current treatment options are non-specific and often cause significant side effects. Thus, there is an urgent
need to identify the immune factors and relevant mechanisms that can be targeted therapeutically to treat
idiopathic NS such as FSGS and prevent recurrence of the disease.
We recently discovered that BM-derived immature myeloid cells are a main source of circulating soluble
urokinase receptor (suPAR) and contribute to proteinuric kidney diseases such as FSGS. These findings suggest
that the BM is not simply a place for blood cell production, but is also a central and upstream regulator of kidney
function by acting as the source of soluble factors such as suPAR. Consistent with results seen in mice, our
preliminary data shows that patients with ESRD have high levels of TNFa and suPAR in both plasma and BM,
reflecting a status of chronic inflammation. Moreover, these patients exhibit myeloid-biased hematopoiesis and
show a robust increase in inflammatory CD14+CD16+ BM monocytes that are found to predominantly express
uPAR. In vitro assays show that TNFa skews hematopoietic stem cell (HSC) differentiation towards monocytic
lineage cells at the expense of granulocyte production. Along with the altered myelopoiesis, we found that TNFa
markedly increases uPAR expression, suPAR secretion, and promotes production of proinflammatory cytokines
including TNFa, IL-8, and IL-6.
Based on our published and preliminary data, we hypothesize that inflammatory signals alter BM myelopoiesis
leading to renal injury in certain forms of glomerular diseases and that this can be treated or reversed by
correcting the inflammation-driven BM alteration. To test this hypothesis, we will precisely define the nature of
the BM immune alteration in renal disease (Aim 1), determine how the BM immune factors drive renal injury
(Aim 2), and test if BM correction improves renal function (Aim 3). Importantly, the identification of immune
factors and relevant mechanisms in patients diagnosed with kidney disease will improve the current stratification
of the disease and help to develop novel therapies for certain forms of proteinuric kidney diseases currently
categorized as ‘idiopathic’.

Public health relevance
Project Narrative Development of specific therapies for idiopathic renal disease has been hampered by poor stratification of disease entities and a lack of understanding of underlying disease mechanisms. Our published and preliminary findings highlight a novel and central role for the bone marrow immune system in the pathogenesis of renal disease. Thus, we aim to explore the bone marrow-kidney axis as a novel target that improves current patient stratification and provides targets for the eventual development of effective treatments.